Enhancing anti-PD-1 blockade antitumor efficacy by oncolytic virotherapy-mediated tumor microenvironment immunomodulation

PROJECT SUMMARY
Immunotherapy with immune checkpoint inhibitors (ICIs) has been a significant breakthrough in lung cancer (LC)
treatment, yet many patients do not fully benefit from ICIs. Abnormal antigen presentation, the immune-
regulatory tumor microenvironment (TME), plus other factors contribute to primary or secondary resistance to
ICIs. Therefore, there is an evident clinical unmet need to develop approaches to overcome LC resistance to
ICIs. The long-term goal is to accelerate development of transductional targeting OAdSA-4-1BBL, an oncolytic
adenovirus targeting preferentially transferrin receptor (TfR) in LC cells and that expresses a novel co-stimulatory
molecule streptavidin-4-1BBL to treat non-small cell lung cancer (NSCLC) patients unresponsive to ICIs. The
overall objective for this proposal is to evaluate the effectiveness of OAdSA-4-1BBL alone or combined with anti-
PD1 blockade in an immunocompetent orthotopic lung cancer mouse model and develop a novel OAd
expressing SA-human4-1BBL that preferentially infects and kill LC cells by targeting transferrin receptor (TfR).
The central hypothesis is that OAdSA-4-1BBL-mediated immunomodulation of the TME promotes durable
protective antitumor immunity to overcome resistance to ICIs in NSCLC, and that combined therapy OAdSA-4-
1BBL plus ICI will synergistically and permanently eradicate NSCLC tumors. The rationale for the proposed
study is that rigorous scientific evidence supports an immunotherapeutic role for OAdSA-4-1BBL in an
immunocompetent orthotopic LC host in settings of ICIs. Further, selectivity of TfR/OAdSA-h4-1BBL in patient-
derived organoids (PDOs) likely provides a strong foundation for the development of clinical approaches testing
TfR/OAdSA-h4-1BBL as a novel strategy to boost the effects of ICIs in NSCLC patients. Guided by strong
preliminary data, the following specific aims are proposed: 1) Evaluate the immunotherapeutic efficacy of
OAdSA-4-1BBL alone or in combination with anti-PD-1 blockade in an orthotopic LC mouse model and 2)
Development and characterization of transductional targeting-(TfR) OAdSA-h4-1BBL in a PDOs. For Aim 1,
syngeneic orthotopic lung tumor models expressing luciferase will be used to monitor antitumor efficacy of
OAdSA-4-1BBL alone or in combination with anti-PD-1 blockade, OAdSA-4-1BBL-mediated immunogenic cell
death will be evaluated, flow cytometry for immune cell phenotyping from tumors, lymph nodes, and spleen will
be used to evaluate OAdSA-4-1BBL capacity to reprogram the TME. In Aim 2, an improved transductional
targeting (TfR) OAd expressing SA-human-4-1BBL will be developed and tested in clinically relevant PDOs. The
proposed research is novel because it combines a cancer selective tumoricidal agent with a novel, chimeric, and
soluble co-stimulatory molecule SA-4-1BBL in one single agent that could overcome LC resistance to ICIs. The
proposed research is significant because the results are expected to provide strong justification for continued
development and future clinical trials using OAdSA-4-1BBL in combination with ICIs. Apart from advancing
the field of oncolytic immunotherapy in NSCLC, this new generation of immunotherapies is expected to benefit
patients with other cancer types that are also resistant to ICIs.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because some non-small cell lung cancer patients do not fully benefit from immune checkpoint inhibitors, and thus development of strategies to overcoming treatment resistance is urgently needed. The proposed research is relevant to the part of the NCI's mission that pertains to supporting cancer research across the nation to advance scientific knowledge and help all people live longer and healthier lives.